POWER CONSIDERATIONS WHEN DECIDING TO USE TRANSFORMATIONS

Conventional wisdom suggests that data derived from relatively small studies which have skewed distributions be transformed (log, square root, etc.) before analysis. Alternatively, one might consider some non-parametric procedure involving a rank transformation to perform a permutation type procedure. To demonstrate the effect of specific alternatives on both the type I error and power of detecting differences between treatment groups, simulation studies were conducted using specific gamma distributions G(alphaphi) to generate the data. A two independent sample study design was assumed. The values of alpha assumed were 1, 2, 4, 8, 16, representing a wide class of distributional profiles from almost symmetric (alpha = 16) to highly skewed (alpha = 1 or 2). The mean disease level mu = alphaphi = 3.0, and test group always had means corresponding to 0%, 10%, 20%, 30%, 40% and 50% reductions (RT) in average disease level. Five thousand pairs of random samples of equal size were selected from these distributions. Group sizes considered were n = 10, 15, 25 and 40. Six statistical test procedures were compared: the UMP test; t-tests based on the original, square root and logarithmic scales, respectively; the Wilcoxon ranksum test; and the randomization test (based on mean differences). Necessarily the UMP test (not a realistic option in practice) produced the greatest power for all combinations of n, alpha and RT. The power losses associated with the randomization test were rather small, ranging from 2% to 4% (absolute differences) over the range of alternative investigated; the power loss associated with the t-test on the original scale as well as the square root scale were slightly larger (3% to 6%) for n = 10 and 15, but these t-tests performed about equally to the randomization test for group sizes of 25 or more. The power loss associated with the t-test on the log scale was surprisingly substantial, ranging from 5% to 10% relative to the t-test on original scale. The wilcoxon test produced similar results of that of the t-test on log scale.